Using NAD+ precursor for treatment of global cerebral ischemia

Summary:
Ischemic brain damage due to cardiac arrest or stroke is one of the most complex pathophysiologic
processes. To successfully treat ischemic brain injury, one need to target several cellular pathways and
cell-type within the brain.
NAD+ is an essential cofactor involved in multiple bioenergetic reactions and its degradation
after ischemia leads to pathologic cellular metabolism and inhibition of energy production. The majority
of cellular NAD+ is re-synthetized via the salvage pathway, where nicotinamide mononucleotide (NMN)
is converted to NAD+. Our recent studies demonstrated that administration of NMN dramatically
ameliorates ischemic brain injury following transient global cerebral ischemia. Furthermore, NMN
treatment inhibited post-ischemic NAD+ catabolism, reduced poly-ADP-ribose generation, and reversed
the excessive mitochondrial fragmentation. Finally, the ischemia-induced changes in mitochondrial
protein acetylation were inhibited in NMN injected animals. Overall goal of this proposed project is to
develop the most effective treatment strategy utilizing NMN that will dramatically reduce ischemic brain
damage and characterize the mechanism of its neuroprotection. We hypothesize that NMN
administration after ischemia will significantly inhibit neurodegeneration due to its multi-targeted effect
and ability to improve mitochondrial functions and cellular bioenergetics.
Specific Aim 1 is focused on the NMN-induced protein acetylation mechanisms that modulate
mitochondrial dynamics and function. The role of Sirt1 and Sirt3 dependent deacetylation in
mitochondrial fusion and fission will be determined using our transgenic animal models that
concomitantly express mitochondria targeted eYFP and Sirt1 or Sirt3. Additionally, SIRT1, and SIRT3
knockout animals will be used as tools for inhibition of deacetylase activity. In specific Aim 2, we will
perform time-dependent studies of NMN administration following global cerebral ischemia in mice. We
will use unbiased stereological quantification of neuronal cell death, and multiple cognitive tests will be
performed to assess the efficacy of treatment. The recovery periods will vary from 7 days up to 6
months after ischemic insult. In specific Aim 3, we will determine the neuroprotective effect of the NMN
treatment by using the most neuroprotective protocol determined in Aim 2 on female and aged animals.
The significance of this work is that it proposes to identify NMN as a protective compound that
will significantly impact the clinical application of NAD+ precursors as therapeutic compounds for acute
brain injury and potentially reveal new targets for neuroprotection.

Public health relevance
Project Narrative Survivors of heart attack or stroke-induced brain injury suffer from many log-term physical, cognitive, psychological, and emotional impairments. By focusing specifically on understanding injury mechanisms that leads to mitochondrial and ultimately cellular bioenergetics failure, the research in this grant will promote the development of treatments with the ability to improve the long-term clinical outcome for stroke victims.